A Generalizable Photo-Crosslinking Strategy to Identify Tyrosine Phosphatase Substrates

PROJECT SUMMARY
Protein tyrosine phosphorylation is a common mechanism for relaying essential information in animal cells, and
many cancers are driven by aberrant tyrosine phosphorylation events. This protein modification is mediated by
two classes of enzymes: tyrosine kinases and tyrosine phosphatases, which phosphorylate and
dephosphorylate, respectively, thousands of different proteins. Many tyrosine kinases are extremely well-
characterized and are the targets of numerous clinically-approved cancer therapies. By contrast, most tyrosine
phosphatases are not biochemically well-characterized, and in particular, we do not know the specific
proteins that many of these enzymes dephosphorylate. Despite this dearth of knowledge, we known that a
few tyrosine phosphatases directly contribute to cancer signaling, and genetic evidence suggests that many
more are likely to be important cancer drivers, tumor suppressors, or modulators of the immune response against
cancer cells. In order to elucidate the precise roles of individual tyrosine phosphatases in cellular processes, we
need tools to rapidly and reliable identify their substrates. Here, we propose a strategy to identify direct
substrates of tyrosine phosphatases in live cells, by combining protein engineering and mass
spectrometry-based proteomics.
A major challenge in the identification of tyrosine phosphatase substrates is that their interactions with their
cognate enzymes are weak and transient, making them difficult to isolate from complex proteomic mixtures. To
solve this problem, we will use genetic code expansion to introduce light-activatable crosslinkers into
tyrosine phosphatases. In Aim 1, we will combine structural and evolutionary information to identify ideal
positions on tyrosine phosphatases to place photo-crosslinkers, such that they do not perturb phosphatase
function but can irreversibly capture a substrate when exposed to UV light. We will test out candidate positions
on a model tyrosine phosphatase, PTP1B, with three different photo-crosslinkers. In Aim 2, we will examine the
generality of our best designs by testing them on several tyrosine phosphatases and an array substrates. In Aim
3, we will establish methods to express the engineered tyrosine phosphatases in live mammalian cells, induce
the capture of substrates with UV light, and identify those substrates using mass spectrometry. We will compare
our strategy to the current state-of-the-art method, which relies on mutations in tyrosine phosphatases that
significantly disrupt their function and only modestly stabilize their interactions with substrates.
Successful development of our photo-crosslinking method will enable efficient identification of the
substrates of any tyrosine phosphatases in virtually any cell line of interest. This technique could be used
to delineate the roles of individual tyrosine phosphatases in cancer signaling and cancer-relevant immunity.

Public health relevance
PROJECT NARRATIVE Tyrosine phosphatases are emerging as an important class of enzymes in cancer signaling, and many members of this enzyme family could be fruitful drug targets for precision medicines and immunotherapies. While genetic evidence supports a role for many tyrosine phosphatases in cancer etiology and therapeutic response, it has been technically challenging to obtain detailed knowledge of the specific cellular functions of these proteins. In this project, we will develop a robust protein engineering strategy to identify direct substrates of individual tyrosine phosphatases in live cells, thereby allowing us to pinpoint specific biochemical functions across this important enzyme family.